The role of pseudouridine synthases in autophagy

PROJECT SUMMARY/ABSTRACT
The balance between cell death and survival is a critical factor for maintaining human health. Cells must rapidly
adapt to stress conditions within their environment to survive. Cytoprotective measures require the cell to process
stimuli, and often, alter gene expression within regulatory circuits. The ability to design and build synthetic cells
for innovative biomedical applications requires a complete understanding of how critical cellular pathways are
regulated. However, a comprehensive model for how a single cell functions has remained elusive. This gap in
knowledge is a major barrier to developing synthetic cells for biomedical purposes. Thus, there is an urgent need
to elucidate molecular mechanisms required for cell survival. Macroautophagy/autophagy is an essential
mechanism that preserves cell health under homeostatic conditions and supports survival under stress.
Autophagy is a dynamic pathway of cellular degradation and recycling that is conserved from yeast to humans.
Basal autophagy is low, but is markedly upregulated during stressful conditions. At present, >40 autophagy-
related (ATG) genes have been identified in yeast; many of these genes are conserved in humans. This
complexity requires the cell to maintain precise control over autophagy at multiple regulatory levels. Despite this
need for strict regulation, much remains unknown about how autophagy is fine-tuned in the cell. In humans,
perturbation of autophagy can have deleterious effects on cell health and survival, contributing to disease
pathogenesis. In fact, aberrant autophagy is associated with diverse human pathologies such as
neurodegeneration, cancer, and lysosomal storage and metabolic disorders. The rationale for this project is that
there is a gap in our understanding of the molecular mechanisms driving responses necessary for cell survival
under stress conditions. Our objective is to determine the role(s) of Pseudouridine synthases (Pus7 and Pus4)
in nonselective and selective autophagy. Pus enzymes catalyze the RNA-independent isomerization of uridine
to pseudouridine (Ψ). Our hypothesis has been developed based on preliminary data that was generated using
the budding yeast model system. The yeast system provides numerous advantages, including the ability to
perform biochemical and molecular genetic experiments quickly and easily, and in ways that are suitable to
actively engage undergraduate students in authentic biomedical research. Since autophagy is highly conserved
from yeast to humans, we expect that our findings from this project can be applied to furthering our understanding
of cell survival in humans. This project will increase the participation of undergraduates in a rewarding biomedical
research experience at Oakland University, which is in the Detroit metro area. This project is innovative because
it provides insight into the mechanistic role(s) of Pus7 and Pus4 in cell responses to stress and uses innovative
approaches to do so. The proposed work is significant because it advances our knowledge of the physiological
roles of Pus enzymes in cells and how cells dynamically respond to environmental stress. This project will
generate fundamental knowledge required for understanding cell survival mechanisms under stress conditions.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because autophagy dysregulation is an underlying cause of human diseases, such as cancer, neurodegeneration, and lysosomal storage disorders. This project addresses the gap in our understanding of how autophagy – an essential pathway for managing cell stress – is regulated at the molecular genetic level. Thus, the proposed research is relevant to the part of the NIH’s mission to foster fundamental discoveries as a basis to significantly advance the capacity to protect and improve human health.